Equipping a newly renovated ABSL-3 suite with a "smart" biocontainment caging system

ABSTRACT
Animal Biosafety Level 3 (ABSL-3) studies have increase nearly 50% from pre-pandemic, in large part, by SARS-
CoV-2 research and is now nearing ABSL-3 housing capacity limit in the current Yale Animal Resources Center
(YARC) ABSL-3 facility. To remedy the ABSL-3 space shortfall, a $4.25M university-funded renovation of the
Laboratory of Epidemiology and Public Health (LEPH) 8th floor animal facility includes restoring two previously
decommissioned ABSL-3 animal suit to its original ABSL-3 use. Renovating LEPH 8 ABSL-3 suite to meet current
ABSL-3 standards will provide basic criteria required for conducting ABSL-3 work but the renovation does not
“move the needle” towards more efficient and safer rodent ABSL-3 research. YARC proposes to equip two LEPH
8 ABSL-3 animal rooms with a total of five Tecniplast DVC® IsoCage N biocontainment cage system (and one
rotator) with a newly available home-cage monitoring system to fully leverage use of the new ABSL-3 suite. These
“smart” biocontainment cages will transform use of the new ABSL-3 suite by 1) adding an additional level of
biocontainment for maximum personnel protection through sealed, negative pressure caging system with cage
level HEPA filtration. This additional cage level safeguard will lessen concerns over the use of multiple BSL-3
agents within one room, thereby maximizing the flexibility of the two animal rooms; 2) automated evaluation of
cage bedding conditions (wetness) will result in objective data that quantifies when cage changing is required.
This system standardizes cage conditions and avoids unnecessary cage changes, given static cage are typically
changed on a 7-day cycle, regardless of need. The ventilation combined with automated cage wetness indicator
will extend the cage change cycle to 14 days and beyond, especially for cages with lower numbers and/or smaller
mice. The “change on demand” approach reduces labor by providing objective bedding condition data, potential
exposure to BSL-3 agents during cage changes from reduced cage changes and decreases the amount of waste
generated (up to 50% less). The wetness indictor system will also send emergency alerts if cage flooding is
detected from the water source (or otherwise), guarding against catastrophic animal loss; and 3) automatic and
continuous monitoring and analysis of spontaneous animal locomotion resulting in enhanced animal welfare
monitoring. Since most ABSL-3 studies result in clinical disease that correlates with activity levels, the ability to
continuously monitor activity remotely will revolutionize animal monitoring. Investigators will be able to target when
in-person monitoring is needed, better pinpoint endpoints to subvert unnecessary animal (and data) loss and
decrease the amount of unproductive time and personal risk associated with unnecessary/excessive entry into
ABSL-3 space. Taken together, occupational safety, housing efficiency and animal monitoring stringency will be
increased while labor, PPE and medical waste disposal costs will be decreased.

Public health relevance
NARRATIVE Animal Biosafety Level 3 (ABSL-3) studies have increase nearly 50% from pre-pandemic driven, in large part, by SARS-CoV-2 research and is now nearing ABSL-3 housing capacity limit in the current Yale Animal Resources Center (YARC) ABSL-3 facility. Renovating LEPH 8 ABSL-3 suite to meet current ABSL-3 standards will provide basic criteria required for conducting ABSL-3 work but the renovation does not “move the needle” towards more efficient and safer rodent ABSL-3 research. YARC proposes to equip two newly renovated LEPH 8 ABSL-3 animal rooms with five Tecniplast DVC® IsoCage N biocontainment cage system (and a 6th “rotation” rack) with a newly available home-cage monitoring system to optimize animal monitoring and occupational safety and decrease labor, PPE, and regulated waste disposal.